Leadership and Administrative Core

LEADERSHIP AND ADMINISTRATIVE COMPONENT SUMMARY
The Leadership and Administrative Core (LAC) will provide the organizational framework for the Columbia
Center for Interdisciplinary Research on Alzheimer’s Disease Disparities (CIRAD). The goal of CIRAD is to
provide a training, pilot funding, and mentoring infrastructure that leads to enduring careers and leadership in
AD/ADRD research among early investigators from historically excluded backgrounds. The CIRAD network
includes researchers at the four schools of the Columbia University Irving Medical Center including Physicians
and Surgeons, Nursing, Public Health and Dental Medicine, mentors from the Taub Institute for Research on
Alzheimer’s Disease and Aging, the Columbia University Alzheimer’s Disease Research Center (ADRC), the
Columbia Butler Aging Center, and the New York State Psychiatric Institute. Over the next funding period, CIRAD
will prioritize collaborative partnerships with regional Minority Serving Institutions such as the City University of
New York and the State University of New York, and will maintain existing relationships SUNY Downstate, NYU,
Weill Cornell Medical Center, Montefiore Medical Center and Albert Einstein College of Medicine, as well as other
institutions around the country. CIRAD faculty, mentors, and scientists were active within collaborations with
other NIA programs and centers during the first funding period. The LAC will provide the scientific and
administrative leadership and infrastructure to: a) support training, a pilot studies program, community
partnerships, and a mentoring program in ADRD research and in health disparities for early career scientists
from underrepresented backgrounds; b) enhance and accelerate critically-needed ADRD disparities research at
CUIMC, in the New York City area, and nationally, and c) support innovative, effective, and empirically-based
techniques for recruiting and retaining minoritized and population-representative research participants, and
dissemination of those techniques to other RCMARs and the ADRD research community; d) create partnerships
and engage with the communities of New York City to enhance the relevance, success, and impact of ADRD
research. The LAC will achieve its goals through the following specific aims: Aim 1: Provide innovative scientific
leadership and administrative support for all CIRAD activities to ensure that the research focus on equity in
ADRD is maintained, and serve as a resource for ongoing activities in research on ADRD disparities. Aim 2.
Coordinate and support the integration of CIRAD Cores and leveraged resources in order to meet the training,
research, and community engagement goals of the center. Aim 3. Support communication and dissemination
of CIRAD activities within CUIMC, partner institutions in New York City, NIA, other RCMAR programs, and
nationally. Aim 4. Evaluate CIRAD activities.